Feasibility of early detection of infection and sepsis in the home

PROJECT ABSTRACT
Sepsis, the systemic manifestation of infection, causes complex and costly hospitalizations with unacceptably
high morbidity and mortality. Most research focuses on detection of the sepsis within the hospital; however, most
sepsis is community-acquired and thus begins in the home. Nightingale Labs has developed a fully automated
non-contact home bed sensing platform that detects signatures of hospitalizations without requiring any patient
participation. Here, we will test whether the technology can be used to detect infections or sepsis. This SBIR
proposal will evaluate the feasibility (Phase 1) and execute (Phase 2) a prospective observational study to learn
the signatures of impending hospitalizations for localized or systemic infection. The work will substantially expand
the toolkit for facilitating early recognition and intervention to reduce infection- and sepsis-associated morbidity
and mortality.

Public health relevance
PROJECT NARRATIVE Sepsis is a costly and often fatal condition that results from spread of localized infections. In the hospital, early detection of sepsis makes it possible to start antibiotics sooner and improve outcomes; however, most sepsis begins outside of the hospital, in the home. This proposal aims to use sensors in the home bed to recognize early signs of infections and sepsis and to improve care.